Administration & Coordinating Core

PROJECT SUMMARY – ADMINISTRATIVE & COORDINATING CORE The Administrative & Coordinating (AC) Core for the Partnership to Assess Viral and Immune Landscape Intersections with ONcology for People Living with HIV (PAVILION) will be based at Moffitt Cancer Center under the leadership of principal investigators Drs. Anna Giuliano, Anna Coghill, and Hennie Botha, collectively the MPIs. The AC Core’s overarching goal is to provide overall scientific leadership and operational and financial oversight of the PAVILION U54 partnership. Further, the AC Core is responsible for ensuring clear lines of communication within the partnership, overall scientific rigor and reproducibility through a robust Protocol Development & Implementation Team and planning and evaluation activities. PAVILION will seek consult from the External Advisory Panel and the national HIV-Associated Malignancy Research Center (HAMRC) network. As the backbone of the PAVILION partnership, the AC Core is essential for ensuring the short- and long-term success of the partnership and has organized its support of the partnership into three key areas: Aim 1: Provide leadership, administrative, organizational, logistical, and communication oversight and support to the entire PAVILION team This aim includes activities related to the overall leadership of the PAVILION team and administrative and financial oversight of all projects, cores, and developmental projects to ensure that the aims of each are successfully met on budget and in a timely fashion. Aim 2: Provide experiential training opportunities for PAVILION early career investigators to develop leadership skills and experience through mentored participation in key partnership activities This aim focuses on mentoring PAVILION early career investigators to become leaders in international partnerships. Aim 3: Establish and maintain an External Advisory Panel to advise the PAVILION team and to provide a conduit to established Community Advisory Boards within the LMIC partnering countries This aim focuses on planning and evaluation activities related to establishing, maintaining, and liaising with an External Advisory Panel (EAP) and working with established Community Advisory Boards through EAP members.

Public health relevance
PROJECT NARRATIVE – ADMINISTRATIVE & COORDINATING CORE The Administrative & Coordinating (AC) Core for the P artnership to A ssess V iral and Immune L andscape Intersections with cology for People Living with HIV (PAVILION) is the backbone of this U54 research center and is essential for ensuring the short- and long-term success of the team by providing overall scientific leadership and operational and financial oversight of the partnership. Further, the AC Core is responsible for ensuring clear lines of communication within the partnership, overall scientific rigor and reproducibility through a robust Protocol Development & Implementation Team and planning and evaluation activities including consultation from the External Advisory Panel and the national HIV-Associated Malignancy Research Center (HAMRC) network.